Cancer Prevention and Control Research Program

UWCCC Cancer Prevention and Control (CPC) Program Summary
Co-Leaders: Hasan Mukhtar and Amy Trentham-Dietz
PROJECT SUMMARY/ABSTRACT
The Cancer Prevention & Control (CPC) Program spans basic, clinical, and population science to identify
effective approaches to reduce the burden of cancer for patients, their families, and communities through
improved prevention, early detection, and survival. In support of this overarching goal, the CPC program has
defined three thematic aims. Theme 1: Identify promising chemopreventive targets and agents to test in
clinical trials. Members build on a comprehensive integrated understanding of agents that decrease the
incidence of cancer or its progression to clinically significant disease through drug development and clinical
testing. Theme 2: Identify and implement effective approaches to reduce tobacco-related cancers.
Members conduct intervention studies of innovative tobacco cessation approaches and lead observational
cohort studies of real-world smoking patterns. Research focuses on underserved and minority populations
since these are the same groups among whom the prevalence of smoking is greatest. Theme 3: Identify new
strategies to improve the delivery of cancer care. Members identify effective approaches for delivering
cancer screening and diagnostic tests and cancer therapies. CPC members are using innovative simulation
modeling, bioinformatics, and multidisciplinary teams to improve the early detection of cancer; to leverage
insights obtained through analysis of large databases to test approaches for improving access to guideline-
concordant clinical care; and to incorporate patient-centered outcomes. CPC projects directly address the
priorities present in the UWCCC catchment area and support reduction in cancer health disparities. The CPC
Program has 33 members in 14 departments and 4 schools/colleges. Since 2012, CPC members have
published 776 peer-reviewed manuscripts (25% intra-programmatic, 22% inter-programmatic). PIs were
responsible for $11.1 million (direct costs) overall in peer-reviewed grant funding, with 60%, $6.7 million from
NCI. Recent programmatic changes include new leadership, Dr. H. Mukhtar and Dr. A. Trentham-Dietz, and
increased focus on interventions to reduce cancer and cancer risks in our communities. The CPC Program
supports inter- and intra-programmatic interaction through pilot grants, seminars and retreats, a strong
mentorship program, and collaborative working groups. Guided by strategic planning, priorities for the CPC
program over the next 5 years include emphasizing cross-aim collaborations, building on existing momentum
in health services research, and translational disparities research addressing needs in the UWCCC catchment
area.